Trypanosome flagellum structure, assembly, and mechanism

PROJECT SUMMARY
The flagellated protozoan parasite Trypanosoma brucei is responsible for African trypanosomiasis (i.e.,
sleeping sickness), which causes widespread mortality and morbidity of humans and livestock in sub-Saharan
Africa. Sleeping sickness is fatal if untreated, yet no vaccine exists and diagnostic on the field is limited. T.
brucei is also a model organism for other devastating trypanosomatid parasites, notably T. cruzi and
Leishmania spp. Therefore, there is a pressing need for research to better understand these parasites and
facilitate development of new therapeutic interventions. T. brucei and all trypanosome pathogens depend on
their flagellum for motility and signaling in response to the host environment, interaction with host tissues, cell
morphogenesis and division. The T. brucei flagellum is demonstrated to be essential for parasite’s
transmission through its fly vector and infection of the mammalian host. Significantly, the flagellum of these
pathogenic parasites all fashion a prominent, lineage-specific paraflagellar rod (PFR), attached to the
conserved axoneme consisting of 9 doublet microtubules (DMT) + 2 central pair microtubules (CP) and
projections. By cryogenic electron tomography (cryoET) and microscopy (cryo-EM), we have determined the
architecture and molecular arrangement of the intact T. brucei axoneme with PFR and the atomic structures of
its isolated DMT with 154 different axonemal proteins, including 40 proteins unique to the trypanosome lineage
(Xia et al. Science, in press). These structures and knock-down functional studies point to our overall
hypothesis that PFR and other lineage-specific proteins underlie trypanosome-specific motility that drives
infection and transmission. We propose to test this hypothesis by determining the entire flagellum structure,
mechanisms of assembly, and mechanisms of operation. Specifically, we will employ cutting-edge cryo-EM
determine atomic structures of PFR and carry out structure-guided functional and biophysical studies (Aim 1).
We will generate models for flagellar assembly and motility based on chemistry of protein side-chain
interactions. We then use sophisticated molecular genetics, biophysical and motility analyses to directly
interrogate predictions of these models. Aim 2 will focus on the structure and function of T. brucei CP and its
associated, lineage-specific projections. Lastly, we will uncover the in situ structures the flagellum as attached
to the T. brucei cell (Aim 3). This project harnesses currently the worlds’ most advanced Krios G4 microscope
just installed at UCLA, together with mutational analysis and AI-aided data processing methods. The
anticipated atomic-resolution models of the flagellum and structure-guided functional studies focused on
pathogen-specific proteins will unveil potential therapeutic targets for future exploitation in treating neglected
diseases. Broadly, thanks to flagella’s critical role in this and many other pathogenic protozoa, and in normal
human development and health, results should be of wide interest for the community studying pathogenesis of
parasitic protozoa, human development and physiology, and fundamental biology of eukaryotes.

Public health relevance
PROJECT NARRATIVE Trypanosomatids are motile, vector-transmitted protozoan parasites that cause devastating disease in humans and animals. The flagellum of these parasites is essential for motility and signaling that contribute to host- parasite interactions with major consequences for infection, transmission, and treatment of disease. This project will determine parasite flagellum structures, uncover mechanisms of assembly and motility, identify pathogen-specific therapeutic targets.